Project 1 - Sweeney_Hammers

ABSTRACT
The multifaceted pathologies associated with muscular dystrophies, particularly Duchenne muscular dystrophy
(DMD), represent major challenges to the development and clinical implementation of effective therapeutics for
these diseases. AAV gene therapies delivering micro-dystrophin transgenes to all striated muscles are now in
the clinic, with hopes of bringing transformative outcomes course of DMD disease. However, much work is still
needed to advance the safety and efficacy of these therapies before widespread implementation for the
treatment of DMD. In the clinic, there have been serious and fatal responses to viral capsids and the expressed
transgenes. Furthermore, we have found that certain micro-dystrophin designs can hasten onset of lethal
cardiomyopathy in mice. The goal of the current project is to develop next-generation AAV gene therapies for
DMD that a) avoid transgene safety concerns and b) reduce the immune response to vector delivery, thereby
advancing the path to safe, effective, and broad-use AAV gene therapies for muscular dystrophies. In Aim 1, we
will develop novel utrophin-dystrophin chimeric transgenes that are less immunogenic than their micro-
dystrophin counterparts. Aim 2 seeks to improve the design AAV capsids and vector genomes to reduce risks of
provoking severe immune responses during treatment. It is anticipated that progress towards these aims will
significant advancements towards safe and efficacious implementation of gene therapy for DMD and other
muscular dystrophies.